Synthesis at the Interface of Chemistry and Biology

Project Summary/Abstract
The unifying theme of our research on synthetic biology is to utilize the principles of Darwinian
evolution to help us understand or expand the fundamental processes of life. As such, the
application of directed evolution to alter, reconstitute, or expand these processes is paramount.
Establishing an automated continuous evolution system comprised of continuous hypermutation
of a gene of interest by a mutagenic T7 replisome, in combination with continuous culturing of its
microbially tractable host E. coli, will greatly accelerate such evolution campaigns in our lab.
Specifically, this will support our research on orthogonal tRNA/RS pairs for genetic code
expansion, as well as the evolution of therapeutic proteases and enzymes.

Public health relevance
Project Narrative This proposal provides justification for the additional funds requested to support the purchase of a Fynch Bio eVOLVER high throughput continuous culture device. This equipment will benefit our research by expanding our directed evolution toolbox to next generation techniques that rely on continuous hypermutation in continuous culture. Given that directed evolution campaigns are the rate-limiting step for the majority of the projects described in this grant, this equipment will have a significant impact on our productivity and success.